ORTHODONTICS AND CELL BIOLOGY

Dr. Barillas, who is a United States citizen, received her DDS degree from the University of Costa Rica in 1990. She came to Rochester to complete a residency in Advanced Education in General Dentistry. Her area of specialty Orthodontics, particularly as it relates to correction of malformations associated with cleft palate. Basic research programs were very limited at Costa Rica, and Dr. Barillas is excited about the world of basic research that has "opened' for her here in Rochester. Specifically, she is interested in bone metabolism and the cell biology of calcified tissue. Dr. Barillas will enter her basic science program through the University-wide Program in Biology and Medicine. Thus, her first-year experience will provide the opportunity for research rotations and coursework in any of the participating basic science departments. The final choice of a research mentor occurs at the end of the first year of study. Key Words: Bone metabolism, cell biology